MOLECULAR ANALYSIS OF AMELOGENINS

Role of individual amelogenin polypeptides in human dental enamel development; alterations in these amelogenin polypeptides in deranged amelogenesis such as occurs in the heritable disease, amelogenesis imperfecta.